International Association of Fire Fighters' Emergency Responder Training Program

The International Association of Fire Fighters (IAFF) proposes to continue its nonacademic
occupational safety and health training program to meet the specific training needs of fire
fighters. The major objective of this program is to address the burden of occupational safety and
health among fire fighters by providing state of the art training by translating scientific
discoveries into practice through effective education, training, and outreach.
Through this continued cooperative agreement, the IAFF will:
1) Enhance the capabilities of fire fighters engaged in emergency response including
defensive hazmat operations through the delivery of active professionally developed
occupational safety and health training programs that are site-specific and trade specific.
2) Maintain, update and/or create training curricula consistent with the threats posed to
fire fighters and ensure curricula is reviewed and or accredited by appropriate third-party
agencies as available.
3) Utilize innovative program evaluation protocols to demonstrate training effectiveness
and ensure the training program meets and exceeds regulations and national standards
resulting in fire fighters who are capable of performing in an effective, efficient, and safe
manner.

Public health relevance
The International Association of Fire Fighters (IAFF) is proud to be a partner with the National Institute of Occupational Safety and Health (NIOSH) for nearly 24 years. The IAFF has continued its nonacademic occupational safety and health training program to meet the specific training needs of fire fighters. The major objective of this program is to address the burden of occupational safety and health among fire fighters by providing state of the art training by translating scientific discoveries into practice through effective education, training, and outreach. The IAFF recognizes that every emergency call is a potential hazardous materials (HazMat) call. Each year thousands of fire fighters are exposed to chemical and biological hazards in the performances of their duties. The IAFF understands that training students in hazards, defensive actions, and to OSHA and NFPA standards can help minimize and eliminate exposures. Our mission is to train all levels of fire fighters in their own departments and customize the training to meet jurisdictional hazards. IAFF programs are developed and taught by highly trained fire fighters who bring valuable experience to the classroom. IAFF training efforts have proven to reduce risk and protect fire fighters safety and health through effective training.